Neural and affective mechanisms underlying prospective self-control costs

Project Summary
Self-control failures are a universal challenge for healthy and clinical populations. Recent theoretical and
empirical work suggests these failures may arise from excessive cognitive costs associated with exercising
control. However, traditional self-control paradigms do not provide a methodological platform to quantify these
costs. Further, we know little about the neural basis of self-control costs nor how these representations change
under different classes of psychological stress, which is a major risk factor for self-control failure. To address
this, we developed a novel decision-making task that measures how much individuals will pay to restrict access
to tempting rewards that may derail their long-term goals and lead to self-control failure (precommitment). Here,
we aim to use an expanded and refined version of this newly validated tool to examine neurocomputational and
affective mechanisms underlying prospective self-control costs and how they relate to real-world self-control
failures. In Aim 1, we seek to identify the computational, motivational and cognitive mechanism that gives rise to
self-control costs. We will model the cost function for self-control, test how this metric relates to cognitive
constructs typically implicated in self-control in the literature and disentangle the motivational mechanism
underlying the use of precommitment. In Aim 2 we seek to characterize the neural correlates of self-control costs,
track how activity within these regions dynamically fluctuate depending on the feature of food stimuli participants
focus on and identify neural mediators and connectivity patterns stemming from these costs. In Aim 3, we seek
to examine how different classes of stressor type (physiological, social, or lifetime stress) shapes the behavioral
and neural representations of self-control costs. Characterizing individuals’ self-control cost function and how
these costs are represented in the brain will allow for a more direct test of how stress exposure affects decisions
to use self-control and may lead to potential interventions that can buffer individuals from the effects of stress on
such decisions.

Public health relevance
Project Narrative Recent theories suggest that failures of self-control, which are a fundamental part of human behavior and are often triggered by exposure to stress, may emerge because self-control is perceived to be effortful (or ‘costly’) to individuals. Here, we use behavioral, computational and neuroimaging approaches to quantify these self- control costs, identify how they are represented in the brain and examine how they change under different forms of stressor exposure. Identifying behavioral metrics and neural mechanisms for the cost of self-control may offer a more precise approach for predicting when and how stress will compromise self-control processes and further our understanding of self-control failure, which is a transdiagnostic feature across a range of psychiatric disorders.